Cell-to-cell heterogeneity and the emergence of antibiotic resistance

Project Summary / Abstract
Antibiotic resistance is a major clinical challenge, with the propagation of drug resistant strains of bacteria
dramatically outpacing new drugs emerging from the development pipeline. Resistance typically arises when
bacteria undergo genetic modification, either due to acquisition of resistance genes via horizontal gene transfer
or chromosomal mutations. These genetic changes can occur in the presence of antibiotics, which raises the
question of how bacteria can survive antibiotic exposure and go on to express the resistance genes. Recently,
studies on antibiotic tolerance have begun to reveal examples where intrinsic mechanisms can provide low or
temporary protection that allows some cells to survive periods of drug treatment. Expression of tolerance
mechanisms can be stochastic and transient suggesting that this may occur only in a subset of cells and under
specific dynamic gene expression conditions. This project seeks to address key questions related to the initial
steps in the emergence of drug resistance, quantifying how long individual cells remain tolerant, how the
transient dynamics of these tolerance mechanisms impacts antibiotic evasion, and how single-cell level events
result in the spread of antibiotic resistance across populations of cells. Our central hypothesis is that
expression of intrinsic tolerance genes can provide periods of protection, allowing for the acquisition and
expression of drug resistance genes, but that this protection is transient and variable across cells. To test this,
our approach is focused around three complementary Aims: (1) Quantify antibiotic tolerance in interval
between acquisition and expression of resistance genes, (2) Characterize how dynamic expression of genes
involved in antibiotic tolerance impacts survival, and (3) Measure transition to resistance enabled by tolerance
in clinically relevant bacterial populations. This research is significant because precise understanding of the
timescales of tolerance and the mechanisms involved could offer key insights to guide antibiotic dosing
regimens or suggest new drug targets or adjuvant therapy approaches. Innovative elements of the research
include the use of optogenetic control to precisely regulate gene expression in single cells; the integration of
deep learning-based feedback via model predictive control to dramatically increase throughput and precision
when controlling gene expression; and the ability to independently and precisely control resistance gene
acquisition, tolerance gene dynamics, and antibiotic exposure. In addition, the project includes detailed
characterization and comparisons between Escherichia coli K-12 lab strains and clinically relevant bacteria
including Salmonella enterica serovar Typhimurium and E. coli isolates derived from blood and urine infections.

Public health relevance
Project Narrative This proposal focuses on the initial steps in the emergence of antibiotic resistance, looking at how intrinsic tolerance mechanisms may provide a window of protection that allows bacteria to acquire resistance via horizontal gene transfer or mutation. The resulting data will be relevant for revealing novel routes by which bacteria evade drug treatment and can inform treatment strategies to combat the spread of antibiotic resistance.